Circuit maturation and function in postnatal primate retina

PROJECT SUMMARY/ABSTRACT
Establishment of functional neuronal circuits within the retina relies on a period of postnatal maturation. Our
knowledge of this developmental period is restricted to information from non-primate model systems. This project
aims to determine the progression of postnatal maturation across two divergent primary output pathways in the
primate retina– ON and OFF parasol retinal ganglion cells (RGCs) - by correlating functional activity of RGCs
obtained by single cell electrophysiology to expression profiles of synaptic markers and the ultrastructural
synaptic connectivity map underlying neuronal function. Our studies will compare observations from three
postnatal timepoints before visual function and circuit maturation reaches adult profiles. In Aim 1 we will
determine the postnatal development of light evoked functional responses of ON and OFF parasol RGCs
including spike output across luminance levels and intrinsic electrical properties. In Aim 2 we will determine the
postnatal development of excitatory and inhibitory synaptic inputs onto ON and OFF parasol RGCs that regulate
their responses, including expression profiles of constituent pre- and postsynaptic proteins and the 3D
ultrastructural organization of synaptic inputs. Our findings will provide the first insights into the early stages of
postnatal functional maturation across key parallel pathways (ON and OFF parasol RGCs) in the primate retina,
thereby addressing the current knowledge gap about the process of postnatal circuit and synapse maturation
during primate retinal development. Our observations will also reveal if functionally divergent retinal pathways
mature at similar or disparate rates and identify substrates that cause developmental visual deficits. Moreover,
our findings will provide important baseline information about functional maturation of primate retinal neurons
critical for developing lab grown human stem cell derived retinas that mimic functional properties of primate retina
to model and treat a wide range of retinal degenerative diseases.

Public health relevance
PROJECT NARRATIVE The developing visual system undergoes a postnatal period of synaptic refinement when neural circuits are structurally and functionally established. Our work will reveal how key divergent neural circuits within the primate retina reach functional and synaptic maturation in the postnatal period. Our findings will provide novel insights into the developmental trajectory of postnatal maturation for primate retinal pathways, thereby contributing to our understanding of visual dysfunction that arise from developmental disorders.